Environmentally-adaptive nanoparticles with focal irradiation for cancer therapy

ABSTRACT Nanoparticles (NPs) have been widely pursued as a promising tool to increase the biodistribution of an- ti-cancer therapeutics in tumors, thereby reducing the general exposure to chemotherapy. It is generally acknowledged that defective vasculature and lymphatic systems surrounding tumors offer a selective oppor- tunity for NPs to accumulate in tumors. However, the amount delivered to tumors this way is only a small frac- tion (~5%) of the total administered NPs. This challenge may be addressed by decorating the surface of NPs using a tumor-specific ligand, but the benefit is often limited due to the heterogeneity and genetic instability of tumors. Challenges in drug delivery using NPs are aggravated by the limited penetration of NPs into tumors, due to high tissue stiffness and interstitial fluid pressure. Substantive departure from the status quo NP-based drug delivery requires a new strategy to increase the amount of NPs delivered to and retained by tumors beyond the level currently possible based on passive delivery via the so-called enhanced permeability and retention (EPR) effect or other targeting strategies. Our long term goal is to develop a new drug delivery strategy that enhances delivery of nanomedicine into solid tumors to a greater extent than currently achieved. The objective of this application is to enhance the accumulation, retention, and penetration of anti-cancer drugs into solid tumors, via synergistic application of environmentally-adaptive NPs (ENPs) and image-guided radiation-induced permeability (IGRIP). Our central hypothesis is that NPs developing cationic surface or reduced size specifically in tumors will be better retained and/or penetrated in tumors than conventional non-adaptive NPs, and tumor accumulation of such NPs will be actively increased by targeted irradiation that results in local increase of microvascular permeability. The ra- tionale for this project is that its successful completion will enable the delivery of a greater amount of anti- cancer therapeutics to solid tumors than currently achieved with existing technology, thereby enhancing the effectiveness of cancer therapy. We will achieve our objective by pursuing the following three specific aims, where we will optimize the synthesis of ENPs and encapsulation of a model anti-cancer drug, paclitaxel (PTX) (Aim 1) and validate the IGRIP effect in a mouse model of prostate cancer (PCa) and optimize the irradiation regimen for NP delivery (Aim 2). Based on the optimized ENPs and irradiation regimen, we will correlate the pharmacokinetics and biodistribution of PTX delivery and anti-tumor effects in mice with PCa, to test the effec- tiveness of ENPs in PTX delivery to tumors as compared to Abraxane and the IGRIP enhancement of ENP delivery (Aim 3). By the completion of this study, we expect to have confirmed our approach as a valid meth- odology to increase biodistribution of nanomedicine into solid tumors and enhance therapeutic potential.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because a drug delivery strategy that increases deposition of nanomedicine in tumors to a greater extent than currently possible can enhance the efficacy of chemotherapy, minimize systemic side effects, prolong patient survival and improve their quality of life. There- fore, this research is consistent with the mission of the NIH, which pertains to developing resources that will assure the Nation's capability to efficiently prevent and/or treat human diseases. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Nanoparticles (NPs) have been widely pursued as a promising tool to increase the biodistribution of an- ti-cancer therapeutics in tumors, thereby reducing the general exposure to chemotherapy. It is generally ac- cepted that defective vasculature and lymphatic systems surrounding tumors offer a selective opportunity for NPs to accumulate in tumors.7 However, the amount delivered to tumors this way is only a small fraction (~5%) of the total administered NPs.8 This challenge may be addressed by decorating the surface of NPs using a tu- mor-specific ligand, but the benefit is often limited due to the heterogeneity and genetic instability of tumors.8 Challenges in drug delivery using NPs are aggravated by the limited penetration of NPs into tumors, due to high tissue stiffness and interstitial fluid pressure.9 Substantive departure from the status quo NP-based drug delivery requires a new strategy to increase the amount of NPs delivered to and retained by tumors beyond the level currently possible based on passive delivery via the so-called enhanced permeability and retention (EPR) effect or other targeting strategies. Our long term goal is to develop a new drug delivery strategy that enhances delivery of nanomedicine into solid tumors to a greater extent than currently achieved. The objective of this application is to enhance the accumulation, retention, and penetration of anti-cancer drugs into solid tumors, via synergistic application of environmentally-adaptive NPs (ENPs) and image-guided radiation-induced permeability (IGRIP). Our central hypothesis is that NPs developing cationic surface or reduced size specifically in tumors will be better retained and/or penetrated in tumors than conventional non-adaptive NPs, and tumor accumulation of the NPs will be actively increased by targeted irradiation that results in local increase of microvascular permeability. Our pre- liminary results confirm (i) increased cellular retention of ENPs in conditions common to many solid tumors (acidic pH and matrix metalloproteinases, MMPs); (ii) feasibility of producing size-variable NPs according to pH change along the path into tumor tissues and cells; and (iii) increased microvascular permeability upon image- guided localized irradiation. The rationale for this project is that its successful completion will enable the deliv- ery of a greater amount of anti-cancer therapeutics to solid tumors than currently achieved with existing tech- nology, thereby enhancing the effectiveness of cancer therapy. Our research team consists of investigators with complementary expertise, well prepared for undertak- ing the proposed research: Dr. Yeo (PI) with expertise in drug delivery and nanomedicine development; Dr. Kron (co-I) in radiation biology and tumor microenvironment, Dr. Elzey (co-I) in syngeneic and xenogeneic an- imal cancer models, and Dr. Galinsky (co-I) in pharmacokinetics and pharmacodynamics. We will achieve our objective by pursuing the following three specific aims. Specific Aim 1. To optimize synthesis of ENPs loaded with paclitaxel (PTX): The objective is to create ENPs that change the surface properties or size according to the pH or proteinase activity to achieve enhanced tumor retention and penetration. The working hypothesis is that weak acidity or proteinase activity in tumoral ECM causes changes in surface properties or particle size, thereby improving the tumor retention and/or permeability of NPs to a greater extent than traditional non-responsive NPs. Specific Aim 2. To optimize and validate IGRIP for delivery of NPs to prostate cancer tumors in mice: The objective is to investigate the most advantageous radiation dose and timing of NP administration after irradiation to induce IGRIP. We will examine the extent of NP delivery after varying radiation doses and time-delays and evaluate the effect of IGRIP-enhanced NP delivery on tumor regression. The working hypoth- esis is that the optimized radiation dose and timing will increase extravasation and accumulation of PTX- loaded NPs and delay tumor growth to a greater extent than NP or radiation alone. Specific Aim 3. To determine biodistribution and anti-tumor activity of PTX/ENPs: The objective is to evaluate biodistribution of ENPs and effectiveness of PTX delivery using ENPs in a syngeneic mouse model of prostate cancer. The working hypothesis is that ENPs achieve greater tumor accumulation and more effective drug delivery than traditional PEGylated NPs or approved PTX product, especially when the micro- vascular permeability is increased via localized irradiation. By validating this central hypothesis, we expect that we will have solved a bottleneck in NP-based sys- temic drug delivery and validated that our new methodology increases biodistribution of nanomedicine into sol- id tumors and enhances therapeutic potential. The contribution of this project will be significant because the research outcomes provide an experimental basis for overcoming one of the most important challenges in NP- based drug delivery and offer a new therapeutic methodology that can readily translate to clinical practice and improve the effectiveness of chemotherapy of cancer patients.